HIV & Oral Scientific Working Group

PROGRAM ABSTRACT/SUMMARY
SCIENTIFIC WORKING GROUP: HIV AND ORAL HEATH
The Providence/Boston (Prov/Bos) CFAR has established the HIV and Oral Health Scientific Working Group
(SWG) to address research gaps in our understanding of how HIV and associated co-morbidities contribute to
oral diseases and to develop new multidisciplinary research endeavors related to HIV and oral health, with a
focus on supporting early stage investigators. This SWG expands the mission of the Prov/Bos CFAR which is
focused on improving HIV and related health outcomes among vulnerable and marginalized populations
including women, youth, persons with substance use disorders, justice experienced, and those living in resource
poor settings both domestically and internationally. Persons with HIV (PWH) are at risk of many types of oral
diseases including HIV-related opportunistic infections, caries, periodontal disease, and oral cancers including
human papillomavirus (HPV)-related malignancy and squamous cell carcinoma with increased incidence among
PWH who smoke and drink alcohol. Opioid and stimulant use also contribute to oral diseases and poor access
to dental care and oral health screenings can significantly exacerbate these health challenges among PWH. In
addition, there are complex relationships between HIV and the oral mucosa related to chronic inflammation and
mucosal immunity that impact HIV transmission, latency, and treatment. This SWG responds to existing research
gaps by supporting innovative clinical, behavioral, translational, and basic science research intended to reduce
the incidence and morbidity of oral diseases among PWH. Scientific objectives of the SWG include: 1)
Developing and expanding the delivery of HIV testing, prevention, and linkage services in dental clinics to support
the diagnosis, prevention, and treatment of HIV in high-risk populations; 2) Exploring the epidemiology and
natural history of oral HPV) infection, including HPV-related cancer, among PWH; 3) Examining the impact of
tobacco, alcohol, and drug use, and use of oral buprenorphine as treatment for opioid use disorder, as
contributors to oral diseases including cancer among PWH; 4) Advancing diagnostics and treatments for HIV-
related opportunistic infections of the oropharynx; 5) Supporting social and behavioral science research including
examining the impact of HIV-related stigma on access to dental care; and 6) Supporting translational and basic
science research including chronic inflammation in the oral cavity, HIV and mucosal epithelial interactions, HIV
and the oral microbiome, and HIV and immune mechanisms. The goals of the SWG are achieved through 1)
bimonthly SWG meetings; 2) quarterly Steering Committee meetings; and 3) an annual SWG research day. The
goals of the SWG are accomplished by developing new collaborations between HIV, dental, other oral health
researchers, and the CFAR Community Engaged Research Council, to address important scientific questions
prioritized by the National Institutes of Health and by fostering the career development of junior researchers.